ASSESSMENT OF BAROREFLEX CONTROL OF HEART RATE IN PRETERM &TERM INFANTS

Study of the maturational changes in the baroreflex response of heart rate to baroreceptor unloading in developing premature infants.